Cancer Center Support Grant

ABSTRACT
The University of Chicago Medicine Comprehensive Cancer Center (UCCCC) is submitting this competitive
renewal application for its Cancer Center Support Grant for Years 43-47. The mission of the UCCCC is to
elucidate the determinants of cancer, to develop cures for cancer, and to prevent cancer through research,
clinical care, education, and community engagement. Our cancer research programs emphasize translational
and transdisciplinary research, and we pursue this goal by promoting collaboration among a diverse and
dedicated team of outstanding basic, translational, clinical, and population researchers. The 166 members of
the UCCCC are organized into five established programs, all with a translational focus (Molecular Mechanisms
of Cancer; Immunology and Cancer; Clinical and Experimental Therapeutics; Advanced Imaging; and Cancer
Prevention and Control). Clinical research is a major focus of multidisciplinary activity at the UCCCC. The
UCCCC has an extensive record in conducting all phases of clinical trials, and was awarded a U10 NCTN
Lead Academic Participating Site (LAPS) award from the NCI. In addition, the UCCCC is a full member of the
Alliance for Clinical Trials in Oncology, and the Children's Oncology Group (COG), and participates in NRG
Oncology studies as a LAPS main member. In 2016, 914 individual patients were accrued to therapeutic
protocols, with 383 accrued to investigator-initiated trials. In the period since the last review (2013-2016), the
UCCCC contributed 2,121 peer-reviewed publications. Members are supported by $40.5 million (DC) in peer-
reviewed funding, and $23.7 million in non-peer-reviewed funding.
Funds are requested in this application for Program Leaders; Leadership, Planning and Evaluation;
Developmental Funds, Administration, Clinical Protocol and Data Management; the Protocol Review and
Monitoring System, Community Outreach and Engagement; Cancer Research Career Enhancement and
Related Activities; and 10 shared resources (Bioinformatics, Biostatistics; Cytometry and Antibody
Technology; Genomics; Human Immunologic Monitoring and cGMP; Human Tissue Resource Center;
Integrated Microscopy; Integrated Small Animal Imaging Research Resource; Pharmacology; and Transgenic
Mouse/Embryonic Stem Cell Facilities).
Through an in-depth institutional review and multi-faceted strategic planning process, the UCCCC has new
and strong institutional commitments, and a stable and experienced leadership team, and has developed and
implemented a comprehensive strategic plan. Future development will focus on three major initiatives, which
prioritize and accelerate laboratory, clinical and translational, and community-based cancer research:
1) developing new biomarkers, novel treatments, and new interventions to prevent cancer; 2) efficiently
integrating effective treatments and interventions into medical practice; and 3) assessing the impact of these
new approaches on health outcomes, and addressing cancers relevant to our catchment area. Underpinning
each of these initiatives is computation-based models for cancer research and care.

Public health relevance
NARRATIVE The mission of the UCCCC is to elucidate the determinants of cancer, to develop cures for cancer, and to prevent cancer. In addition, we provide education and training for basic scientists, physicians, and clinical investigators, and local health professionals, as well as develop and implement community-based cancer education and outreach programs. Our mission is fulfilled in an environment that values diversity, the development of the next generation of physicians and scientists, and delivering comprehensive and compassionate patient care.